WHCOHH Administrative Core

This Program Project application for the Woods Hole Center for Oceans and Human Health (WHCOHH) is for
renewal of a Center with a strong and integrated set of research projects that involve multiple disciplines in the
ocean and biomedical sciences, communication of that research and engagement with diverse communities.
The overall goal of the Administrative Core is to maintain a structure to facilitate and ensure that
communication, planning, and interaction among Center members occur efficiently, so that the Projects and the
Community Engagement Core (CEC) are integrated and the goals and scientific objectives as set forth by the
Project and Core leaders are achieved. The multi-faceted activities of the Center will be overseen and guided
by the Center Director and Center Co-Director, through the Administrative Core. 1. The Core will oversee and
monitor scientific, outreach and financial aspects of the Center, including grants management, and assure
compliance with data submission and archiving policies for WHCOHH data. The Core will ensure that the
communication and planning of Center activities involve all Center Investigators and Co-Investigators, through
regular meetings and an annual retreat to consider research progress and integration and address problems
and concerns as well as new opportunities. 2. The Core will ensure effective community engagement and
communication of WHCOHH research, working with the CEC Director and Research Project Leaders to identify
opportunities and ensure involvement of Research Projects in community outreach and education, and
engagement with stakeholders and user groups, including resource managers, public health professionals and
seafood harvesters and consumers. 3. The Core will ensure cohesive and impactful evaluation and
management of Center activities, through Internal and External Advisory Committees, which will regularly
review and evaluate the progress and success of Center programs, including the plan for enhancing diverse
perspectives. We also will establish an advisory committee specific to the Community Engagement Core, to
advise on engagement practices. 4. We will maintain contact with relevant offices and program managers at the
NSF and the NIEHS, providing information on progress and responding to specific requests. The Core will
prepare and submit required reports to the NSF and the NIEHS in a timely manner. The Core will facilitate
regular interactions between the WHCOHH and other COHH4 Centers and will help organize the broader
COHH investigator meetings. We will pursue discussion with other Centers in the NIEHS portfolio, engage
collaborators on research relevant to the Center mission and themes, and begin discussion with OHH centers
elsewhere in the U.S. and internationally to broaden the impact of oceans and human health.